Telehealth Exercise and Mindfulness of Pain in knee Osteoarthritis (TEMPO): A digital Feasibility Study

PROJECT SUMMARY/ABSTRACT
Exercise is recommended as the first-line intervention for managing chronic pain in people with knee
osteoarthritis (OA). However, activity and exercise related pain in people with knee OA leads to negative
psychological beliefs including catastrophizing and fear avoidance that make exercise and activity challenging.
Avoidance of activity and exercise perpetuates a vicious cycle of further pain. Racial and geographic disparities
in access to exercise are also a reason for poor utilization. Mindfulness-based interventions can address the
negative psychological beliefs in people with chronic pain and when combined with exercise, may address both
physical and psychological impairments. Also, access to care is increasingly being addressed with the use of
telehealth. This project will determine the feasibility of a novel telehealth mindful exercise intervention. Mindful
exercise refers to application of mindfulness to structured exercise and daily physical activity. In this
randomized controlled trial (RCT), participants with knee OA (n=62) will be assigned to a 10-week, group-
based, telehealth - mindful exercise or only exercise arms. The RCT will be decentralized with recruitment,
intervention, and outcome assessment all being conducted using digital tools including social media, electronic
data capture system, and wearable sensors. The first aim is to determine the feasibility of a telehealth mindful
exercise program compared to telehealth exercise in people with knee OA. The second aim is to examine the
feasibility of a decentralized digital study in people with knee OA. The third aim is to examine the variability in
key knee OA related outcomes in both groups to support the design of the future efficacy study. The long-term
goal of this research is to determine the effectiveness of mindful exercise and translate it to clinical practice to
reduce pain and improve function in people with knee OA. This study will provide information on the feasibility
of the proposed intervention in people with knee OA and will also allow for optimization of digital strategies
before conducting larger decentralized trials of intervention efficacy and effectiveness. The intervention is
informed by a preliminary study aligned with Stage 1A of the NIH Stage Model for Development of Behavioral
Interventions. The proposed study reflects Stage 1B before future efficacy and effectiveness studies can be
undertaken. This research could yield a scalable and equitable intervention that is effective at addressing
negative physical and psychological impact of knee OA, a disease that affects 1 in 10 people over the age of
50 in the US.

Public health relevance
PROJECT NARRATIVE This project is to determine the feasibility of a novel mindful exercise intervention for people with people with knee pain due to osteoarthritis. Additionally, the project will also examine the feasibility of conducting the study via telehealth and using digital tools for improved access to the intervention and recruitment of a racially and geographically diverse cohort of participants. If successful, this line of research may lead to an effective and accessible intervention to reduce pain and improve function for the millions of people with knee osteoarthritis.